Administrative Core

We propose a modest administrative core to oversee the management of the TMEN program. The central administration of the Koch Institute provides Grants and Financial Management, Accounting and Human Resources services so those are not included. Part-time services of an Administrative Assistant are requested to cover necessary administration specific to the program including arranging internal meetings, organizing External Scientific Advisory Board meetings and seminar visitors, including scheduling, and arranging travel, lodging and reimbursement. The AA will also act as intermediary with the central TMEN administration at NCI, preparing progress reports, arranging Principal Investigator/Project Directors (PI/PD) and trainee attendance at TMEN meetings , including scheduling, and arranging travel, lodging and reimbursement.. The AA, Ms. Isadora Deese, will report to the PI, Dr. Hynes, and is located in the same office suite as the PI in the Koch Institute, 1-2 floors away from the central administrative offices and from the laboratory of PD Tyler Jacks, ensuring ease of interaction. We do not propose a more formal administrative structure since the PI and other PDs are all located in close proximity (Koch and Whitehead face each other across the street and MGH is a short walk or a single subway stop away) and meetings are readily arranged as needed. The budgetary structure is simple - each project has Its own budget, two of them funded as contracts to Wl and to MGH and are separately administered within those institutions. Overall monitoring of the budget and financial reporting will be the responsibility of the PI, with assistance from the AA and the Finance Office at the Koch Institute